Mechanistic studies of transthyretin misfolding and amyloid formation through a c

DESCRIPTION (provided by applicant): Protein misfolding and amyloid formation is implicated in numerous diseases such as amyloidoses, prion and Alzheimer's diseases. Prion disease is unique in that the natively folded prion protein forms aggregates with distinct molecular conformations (prion strains), which underlie different disease phenotypes.1-3 The prion strain may be encoded in the primary sequence and mutations of the protein induce different strains, causing distinct disease phenotypes. Recent studies have suggested the strain hypothesis is applicable to other amyloid diseases that also manifest diverse disease phenotypes.1,2,4,5 Nonprion amyloids were shown to exhibit a wide conformational diversity,6-9 which may be linked to the phenotype variations. However, little is known about molecular basis of the diverse misfolding pathways and structural diversity of amyloid. Structural studies of the initial transition from the native state to (partly) unfolded intermediate and the end product amyloid are essential to understanding molecular mechanism of amyloid diversity. Effect of the pathogenic mutations on misfolding pathway should also be examined. The comprehensive biophysical studies have, however, been challenging for previously investigated amyloidogenic proteins due to the limited number of pathogenic mutations associated with distinct disease phenotypes. In addition, the most extensively studied polypeptides, β-amyloid and α-synuclein associated with Alzheimer's and Parkinson's diseases respectively, are natively unfolded, rendering the polypeptides not amenable for mechanistic studies of the initial conformational transition (misfolding). This research program is aimed at investigating amyloid formation mechanisms of a natively folded protein, transthyretin (TTR), using both solution and solid-state NMR. Amyloid formation of wild type and more than 100 mutant forms of TTR are known to cause various amyloidoses with enormous phenotype diversity.10 The main hypothesis of this proposal is that pathogenic mutant forms of TTR may have distinct misfolding pathways, adopting diverse amyloid conformations with different toxic activities, which may result in diverse disease phenotypes and tissue-selective depositions. The hypothesis will be tested through the studies of conformational transition of the natively folded state to (partly) unfolded amyloidogenic intermediate and structural characterization of amyloid. In particular, solid-state NMR with innovative labeling schemes will provide valuable insights into amyloid diversity. Specific aims of the proposal are to explore: (1) Misfolding of the native TTR to amyloidogenic monomer. (2) Structural changes of the native ?-structure during amyloid formation. (3) Effect of the mutations on the misfolding pathway and amyloid structure. Mechanistic understanding of the misfolding and amyloid formation pathways would be critical to developing effective therapeutic strategies for TTR amyloidoses.

Public health relevance
The process by which a polypeptide folds into a unique three-dimensional structure is of critical importance for the proper function of proteins. It is widely accepted that aberrant protein folding (protein misfolding) and subsequent aggregation gives rise to debilitating human diseases. Understanding the molecular mechanism of protein misfolding and aggregation is, therefore, critical to developing new ways to prevent or treat the protein misfolding diseases.